Joslin-BIDMC Postbac Program in Diabetes and Metabolism

ABSTRACT
The United States struggles to cultivate a biomedical research workforce that reflects the diversity of its
population. This challenge is particularly striking in the field of diabetes and metabolic disorders, which
disproportionately impacts racial and ethnic minorities and people from disadvantaged backgrounds. Workforce
diversity is an important goal for social justice and contributes to organizational effectiveness through increased
creativity, broader foundations for decision-making, and a sense of inclusion and belonging in the workplace. In
the field of diabetes and metabolism, a diverse workforce is also critical for broadening participation in clinical
studies. To address this problem, we propose a new Joslin-Beth Israel Deaconess Medical Center (BIDMC)
Post-bac Program in Diabetes and Metabolism to attract talented individuals from diverse backgrounds to pursue
further training and ultimately, careers in biomedical research in metabolic diseases. This program will leverage
Joslin and BIDMC’s broad and deep expertise in diabetes and metabolism and a highly experienced cadre of
mentors who will provide participants with dedicated research experiences, mentoring, coursework, and
professional development activities. The overall goal of our program is to provide participants with the scientific,
technical, and professional skills they will need to pursue doctoral degrees and the inspiration to dedicate their
talents to prevention, treatment, and cure of diabetes and related metabolic disorders. To effectively identify
participants from diverse backgrounds, our program will partner with the Biomedical Sciences Career Program,
a Boston-based non-profit organization dedicated to providing mentorship and career development programs to
individuals from underrepresented groups and disadvantaged backgrounds to promote their success in
biomedical science. We will also reach potential applicants through the online platform, Handshake and by
working with the University of Massachusetts Amherst College of Natural Sciences Career & Professional
Development Center and Harvard College Life Science Research Advisors.

Public health relevance
NARRATIVE The current pipeline of talent is insufficient to improve diversity in the scientific workforce in diabetes and metabolic diseases research. The Joslin-Beth Israel Deaconess Medical Center Post-bac Program in Diabetes and Metabolism will recruit recent post-baccalaureates and provide them with the scientific, technical, and professional skills they will need to pursue doctoral degrees and the inspiration to dedicate their talents for prevention, treatment, and cure of diabetes and related metabolic disorders. By partnering with the Biomedical Sciences Career Program, University of Massachusetts Amherst, and Harvard College and by leveraging Handshake, a well-established online job-posting platform, we will identify and recruit diverse cohorts of post- bac participants to our program.